Safety and Effectiveness of Opioid Tapering among Older Adults

PROJECT SUMMARY/ABSTRACT
The 2016 Centers for Disease Control and Prevention (CDC) Guideline for Prescribing Opioids for Chronic Pain
encourages clinicians to work with patients to lower prescribed opioid doses or to discontinue opioid therapy
when the benefits of continued opioid therapy do not overweigh harms. From 2012 to 2018, the overall opioid
prescribing rate dropped by 37%; meanwhile, prescriptions for high-dose opioids with daily morphine milligram
equivalent (MME) 90 or greater declined by 61% from 2011 to 2018. Older adults with chronic pain, who often
have declining organ function, multiple comorbidities, and taking multiple medications, have been increasingly
targeted for dose tapering to reduce or discontinue opioid therapy. However, despite declining prescriptions for
opioids, opioid-related mortality has not shown a parallel decline, and inappropriate dose tapering (i.e., rapid
opioid tapering) may have contributed to the lack of reduction in opioid-related mortality. We propose to (1)
assess trends in opioid tapering; (2) study the safety of opioid tapering among older patients with CNCP who
were receiving LTOT; and (3) evaluate the effect of opioid tapering on patient-reported outcomes (pain, functional
limitations, and psychological status) among older CNCP patients on LTOT who received home health care.
We will to use the 2012-2018 5% national representative Medicare administrative claims data and the
2012-2018 Medicare Home Health Outcomes and Assessment Information Set (OASIS) data for the proposed
study. Specifically, we hypothesize that: (1) patients undergoing rapid opioid dose tapering are more likely to
experience opioid-related adverse events; (2) among patients with high opioid prescribing continuity, the
association between rapid opioid dose tapering and opioid-related adverse events will be attenuated as
compared to those with poor opioid prescribing continuity; and (3) patients undergoing rapid opioid tapering are
more likely to experience severe pain, functional limitations, anxiety and depression.
Through the three Specific Aims, we are able to evaluate the safety and effectiveness of opioid therapy
among older adults through assessing the patterns of opioid dose tapering as well as through assessing the
benefits and harms of opioid dose tapering. To investigate the Specific Aims, a series of retrospective cohort
and nested case-control studies will be conducted. While opioid tapering shows promise as a method with which
to reduce patient risks and help to alleviate part of the opioid crisis, there is no clear evidence regarding the
benefits and harms of opioid tapering. This is especially apparent in the older adult population due to their
increased risks of adverse events associated with opioid use. The proposed research is significant because it
will contribute to our understanding of the safety and effectiveness of opioid tapering in older adults, which would
have a significant impact on the national efforts in balancing the benefits and harms of LTOT and reducing
prescription opioid use safely.

Public health relevance
PROJECT NARRATIVE The 2016 Centers for Disease Control and Prevention (CDC) Guideline for Prescribing Opioids for Chronic Pain encourages clinicians to work with their patients to lower prescribed opioid doses or to discontinue opioid therapy when the benefits of continued opioid therapy do not overweigh harms. However, inappropriate, rapid tapering of opioids may lead to adverse outcomes such as exacerbation of pain, discontinuation of care, psychological distress, and death. The proposed research will enable a better understanding of the patterns and trends of opioid tapering, the effect of different opioid dose tapering strategies on patient outcomes including clinical safety and patient-reported outcomes, which would have a significant impact on the national efforts in reducing prescription opioid use safely.